Mechanisms of Neurodegeneration in Hereditary Prion Diseases

Prions have become the prime exemplars of self-propagating proteins that cause many devastating
neurodegenerative disorders, including Alzheimer’s disease. Up to 15% of prion disease cases are inherited in
an autosomal dominant fashion, and are caused by point or insertional mutations in the PRNP gene encoding
PrP. The most frequent and highly penetrant mutation is E200K, which is linked to familial Creutzfeldt-Jakob
disease (CJD). Inherited prion disorders pose several fascinating scientific questions: What cellular and
molecular mechanisms account for the pathogenicity of the mutant PrP molecules in these diseases? Do the
neurotoxic effects of the proteins depend on conversion to a self-propagating PrPSc state? Do the mutant PrPs
target primarily the neurons in which they are synthesized, or is there a role for non cell-autonomous
interactions with glial cells? How do astrocytes, which express as much PrP as neurons, contribute to the
disease process? Almost all previous studies of familial prion disorders have utilized transgenic mice or
transformed cell lines as experimental models, typically under conditions of protein over-expression. There is
very little information available on the properties and toxicity of mutant PrPs expressed endogenously by
human neurons or other CNS cell types derived from patients. To fill this gap, the Harris and Mostoslavsky
laboratories have collaborated extensively over the past several years to apply cutting-edge iPSC approaches
to human prion diseases, particularly those of genetic origin. We have been granted access to a large Israeli
family of Libyan Jewish descent harboring the E200K mutation linked to CJD. We have generated of a library
of iPSCs from 22 members of this family, and have used this unique collection to model and study CJD
pathology in iPSC-derived neurons, astrocytes, and cerebral organoids. We have now gathered compelling
preliminary evidence for the emergence in these in vitro systems of disease-relevant phenotypes related to
synaptic structure and transmission. We have also begun searching for protective genetic variants that account
for the markedly delayed onset of symptoms in a small number of “super-resilient” E200K carriers in Israeli and
American cohorts who have lived into their 90s virtually symptom-free. To aid in this search, have amassed a
unique collection of DNA samples from 102 individuals in families from four countries harboring the E200K
mutation. In this application, we propose to extend these promising studies along several fronts, as
summarized in the following specific aims: (1) Analyze the properties of E200K PrP in iPSC-derived neurons
and astrocytes; (2) Analyze how neuronal-glial interactions contribute to the pathogenicity of E200K PrP; and
(3) Use whole-exome sequence data to identify protective genetic variants present in “super-resilient” E200K
carriers. Overall, this project leverages a unique collection of patient samples to elucidate fundamental
pathogenic mechanisms and novel therapeutic targets likely to be shared with other neurodegenerative
disorders like Alzheimer’s disease.

Public health relevance
Prion diseases are fatal neurodegenerative disorders that exemplify fundamental biological principles now known to apply to a wide range of human neuropathologies including Alzheimer’s disease. This proposal aims to establish novel model experimental systems to study inherited prion diseases, utilizing human neurons and other CNS cell types derived from patient-specific, pluripotent stem cells harboring disease-specific prion protein mutations. This platform will allow us to define the specific mechanisms underlying neurodegeneration in inherited prion diseases, and will allow us to evaluate novel therapeutic compounds for treatment of these disorders, as well as for related conditions such as Alzheimer’s disease.